Targeting WEE1 in uterine serous or p53-mutated uterine cancer

PROJECT SUMMARY/ABSTRACT:
PROJECT 1 – WEE1 inhibition in uterine serous carcinomas or p53-mutated uterine cancers
Uterine serous carcinomas (USC) are a distinct histologic subtype of uterine cancer with poor prognosis,
comprising up to 40% of uterine cancer deaths. Similarly, data from the The Cancer Genome Atlas (TCGA)
has shown that p53-mutated uterine cancers are often “serous-like” and have decreased overall survival
compared to other subtypes of uterine cancer. Therapeutic options for this group of patients are limited; in the
recurrent setting, chemotherapy has limited activity and few effective therapies have been identified beyond
the recently FDA-approved regimen of combination pembrolizumab and lenvatinib. Molecularly, these cancers
are characterized by features that suggest the frequent presence of concomitant cell cycle dysregulation
(alterations in TP53, CCNE1, RB1) and high oncogene-driven replication stress (alterations in MYC,
KRAS/NRAS, ERBB2), which might make these cancers particularly vulnerable to targeting replication stress
via WEE1 inhibition. A previous clinical trial of the WEE1 adavosertib in USC at our institution demonstrated
significant clinical activity with a response rate of 29.4%, although targeted next generation sequencing did not
reveal any correlation between specific molecular alterations and clinical activity. The overall objectives of this
project are to (a) assess the correlation between anti-tumor activity of WEE1-targeting agents with functional
and IHC measures of replication stress, (b) explore how IHC measures of replication stress correlate with the
activity of WEE1 inhibition in PDX and GEMM models of p53-mutated endometrial cancers and clinical
samples, and (c) evaluate the correlation of functional and IHC measures of replication stress with clinical
activity of WEE1 inhibition in uterine serous cancer in a biopsy-driven trial. We hypothesize that sensitivity of
p53-mutated uterine cancers is correlated with levels of replication stress and/or the effect of WEE1 inhibition
on replication stress. To test this hypothesis, we will investigate in vitro the effect of WEE1 inhibition on
replication fork dynamics in established endometrial cancer PDO models and the correlation between
functional and IHC measures of replication stress with sensitivity to WEE1 inhibition in these PDOs. We will
further investigate how IHC measures of DNA damage or RS, including γH2AX, pRPA, pKAP1, or pCHK1,
change in vivo after exposure to WEE1 inhibition and whether these measures correlate with in vivo activity
across a panel of established endometrial cancer PDX and GEMMs. Finally, we will assess the correlation of
functional and IHC measures of RS with clinical activity in a biomarker study of the WEE1 inhibitor Zn-c3 in
USC through the establishment of co-clinical PDO models from trial biopsy samples. The findings from these
studies will provide important mechanistic insight into how RS underlies sensitivity to WEE1 inhibition and can
also further inform the development of this novel therapeutic target and potential future biomarker development
for targeting WEE1 in USC and p53-mutated uterine cancers. These findings may also provide insight into
extension of WEE1 inhibition as a strategy in other cancer types.

Public health relevance
PROJECT NARRATIVE: PROJECT 1 – WEE1 inhibition in uterine serous carcinomas or p53-mutated uterine cancers Molecular features of uterine serous carcinoma (USC) and other p53-mutated uterine cancers, a group of uterine cancers with poor prognoses, suggest that these cancers have high “replication stress”, a state where replication of the DNA is slowed and under stress, and may therefore be particularly vulnerable to drugs that target replication stress like a WEE1 inhibitor. A clinical trial with the WEE1 inhibitor adavosertib previously demonstrated significant clinical activity in USCs. In this project, we seek to advance the care and improve outcomes for individuals with USC or p53-mutated uterine cancers by establishing a better understanding of the mechanisms of replication stress and how replication stress is linked to WEE1 inhibitor sensitivity, leveraging assays of replication stress and WEE1 inhibitor sensitivity in patient-derived organoid model systems, immunohistochemical measures of DNA damage and replication stress in mouse model systems, and biopsy samples taken from patients on a clinical trial with the WEE1 inhibitor ZN-c3.